A Mobile Text Approach to Measurement and Feedback for Wraparound Care Coordination

Abstract
Fifteen million children and adolescents in the U.S. experience a diagnosable mental health (MH) disorder, with
approximately half (6 to 8 million) considered to experience a serious emotional disorder (SED). Integrated, multi-
modal community systems to coordinate multiple helpers and provision of multiple interventions have been
identified to address the complex and multifaceted problems faced by youth with SED. One such model, the
Wraparound service model (WSM), has been cited in multiple major reviews of effective community treatments,
and is listed in the Surgeon General's Reports on youth mental health and violence. As is the case for other
evidence-based practices, the degree to which data are consistently measured and used to inform care—i.e.,
“measurement-based care” or MBC—accounts for a large proportion of variance in outcomes for Wraparound.
The goal of this SBIR project is to develop and test the Short Message Assisted Responsive Treatment for
Wraparound (SMART-Wrap) application to overcome the current barriers to measuring and using data in
everyday service settings. SMART-Wrap will facilitate MBC with an SMS system and thus inform and improve
both service and clinical outcomes. In Phase I, we will accomplish four specific aims. First, we will work with a
diverse group of expert advisors, experienced in developing mental health applications and administering WSM
services, to create prototype assessment items and program a web-based `back-end' system for deploying
assessment items via customized SMS. Second, we will assess feasibility of this prototype system for youth with
SED and their caregivers, as well as determine the psychometric properties of the SMS-based items. Third, we
will design and program prototype WSM care team dashboard functions to provide a feasible and acceptable
online system for tracking collected data, identifying key findings, and facilitating MBC. Lastly, we will conduct
an initial pilot test to evaluate feasibility of SMART-Wrap in typical Wraparound service for youth with SED by
having both families and Wraparound care team members use the prototype over a 2-month period. Phase I
quantitative and qualitative data will be used to inform the Phase II R&D plan. The proposed SMART-Wrap
product will harness the simplicity and accessibility benefits of SMS to significantly improve engagement in
Wraparound services and shift current Wraparound practice toward MBC. The end result will be a rigorously
tested new mobile Routine Outcome Monitoring (ROM) solution to help improve service and clinical outcomes
for the over six million youth in the U.S. with SED.

Public health relevance
Narrative Mental health treatments involving measurement-based care are associated with more positive service and clinical outcomes. Short message system (SMS) interventions in particular have been shown to produce significant clinical improvements and positive health behavior engagement, in part due to the highly accessible nature of the modality. The proposed SBIR project will build upon existing services by developing SMS-based technology and assessing its feasibility, usability, and acceptability in typical Wraparound service model settings.